Sustainable Cloud Operations for Research and Environmental Impact (SCORE - EI)

PROJECT SUMMARY/ABSTRACT
The parent project, UZIMA-DS (UtiliZing Health Information for Meaningful Impact in East Africa through Data
Science), aims to create a scalable and sustainable platform that leverages novel data assimilation
approaches and advanced Artificial Intelligence (AI) and Machine Learning (ML) methods to improve health
outcomes in two key domains: maternal, newborn, and child health (MNCH), and mental health (MH). Led by
the Aga Khan University in East Africa (AKU) and the University of Michigan, UZIMA-DS is a U54 Research
Hub funded under the NIH Data Science for Health Discovery and Innovation in Africa Initiative.
Projects in low- and middle-income countries (LMICs) encounter significant challenges with cloud utilization,
such as limited resources, tight budgets, and a lack of expertise in cloud infrastructure. These obstacles hinder
the ability to scale research collaborations within the consortium and beyond. To address these issues, we
propose developing and documenting good practices for building efficient and cost-effective cloud-based data
pipelines for research. We will also address scaling cloud infrastructure responsibly, ensuring that as we
expand, we do so without proportionally increasing our carbon footprint.
We will utilize data pipelines from the ongoing UZIMA-DS project, which processes daily Fitbit data from 500
healthcare workers on a Microsoft Azure instance. This use case will serve as a foundation for building and
evaluating data pipelines using three tools and approaches within the Azure environment. Our primary goal is
to develop and implement good practices for constructing efficient, cost-effective cloud-based data pipelines
that minimize environmental impact. By doing so, we aim to promote sustainable and scalable research
practices in LMIC settings, captured in our motto, “Efficient Data, Sustainable Future for Research.”
The impact of this work includes enhanced research efficiency, cost savings, environmental sustainability, and
empowering the DS-I Africa consortium to adopt sustainable cloud practices.

Public health relevance
PROJECT NARRATIVE As we prepare to scale cloud-first data science projects within DS-I Africa under the UZIMA-DS initiative, a U54 Research Hub funded by the NIH Data Science for Health Discovery and Innovation in Africa Initiative, we propose developing good practices for building efficient and responsible data pipelines for research. These practices will enable leveraging cloud infrastructure on limited budgets while being mindful of our carbon footprint. Using data pipelines from the ongoing UZIMA-DS project, which processes daily Fitbit data from 500 healthcare workers on a Microsoft Azure instance, we will build and evaluate data pipelines using three tools and approaches within the Azure environment. We will measure processing time, costs, and carbon emissions. Our ultimate goal is to achieve “Efficient Data, Sustainable Future for Research” by developing a set of good practices that research teams can use to ensure maximum resource efficiency while minimizing environmental impact.